Transcatheter Intra-Arterial Delivery of Oriented Anti-PD-L1 Immune checkpoint inhibitors Immobilized Nanocarriers for Local Combination Immunotherapy of Hepatocellular Carcinoma

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is the 5th most common malignancy in the world and the 4th leading cause
of cancer death in the US. Resection and transplantation are the sole potentially curative treatments for HCC,
but only 10-15% of patients are candidates. Nivolumab (human anti-PD-1 mAb) was FDA approved in 2017 for
HCC patients previously treated with sorafenib. Recent clinical trials demonstrate the potential of immune
checkpoint blockade (ICB) antibodies against programmed cell death 1 (PD-1) and its ligand PD-L1 for the
treatment of HCC. However, the immune suppressive tumor microenvironment (TME) of HCC leads to a
resistance to ICB immunotherapy and immune related adverse effects (irAEs); thus, the efficacy of ICB
immunotherapy may not be sufficient to elicit durable clinical benefits. Combinational ICB immunotherapies
pairing with immunogenic local therapies are a promising approach for the treatment of HCC. Recently pre-
clinic and clinical trials have tested aPD-L1 ICB immunotherapy in a combination with interventional local
ablation therapies with the promise for enhancing overall therapeutic effects. One limitation that accounts for
the compromised efficacy of systemic ICB immunotherapy in the combination is low tumor specific accessibility
and off-target binding of ICB antibodies to normal tissues upon systemic administration. Tumor site specific
delivery of ICBs will enhance tumoral immune checkpoint blockage efficacy with avoiding systemic non-specific
activation of the immune system resulting in irAEs. Locally delivered ICB conjugated nano-carriers have
enabled the emergence of platforms for safely delivering effective dose of ICBs in the tumor.
We propose catheter-directed intra-arterial (IA) infusion of oriented anti-PD-L1 conjugated ferumoxytol using
Z-domain (aPD-L1-Z-Fer) for a synergistic combination ICB immunotherapy with immunogenic irreversible
electroporation (IRE) local therapy. An engineered Z domain, immunoglobulin G (IgG) Fc domain-specific
binding protein, is proposed to enhance the immune checkpoint blocking efficiency of aPD-L1 with FDA
approved iron oxide nanoparticles (ferumoxytol; Fer). Our recent results demonstrated that Z-domain adaptors
provided a convenient and controlled aPD-L1 ICB conjugation onto Fer (aPD-L1-Z-Fer) and subsequent the
enhancement of immune checkpoint blockade efficiency. Our proposed IA infusion of aPD-L1-Z-Fer will permit
further efficient and targeted delivery of immunostimulatory aPD-L1 to allow an increase in the dosage and
improved safety profile after the immunogenic interventional local ablation therapy for superior therapeutic
outcomes. MRI visible aPD-L1-Z-Fer and MR image guidance should also permit to monitor/track/quantify the
delivery of aPD-L1-Z-Fer to the targeted tumor tissues treated with an immunogenic local therapy. Through a
collaborative project building upon our strengths in nano-immunotherapy, interventional oncology, and
radiology, we seek to develop a powerful new approach for image-guided combinational IA infused aPD-L1-Z-
Fer and immunogenic local ablation for the treatment of HCC.

Public health relevance
NARRATIVE We propose image guided transcatheter intra-arterial (IA) delivery of Z-domain mediated aPD-L1 conjugated ferumoxytol (aPD-L1-Z-Fer) permitting combinational local immune checkpoint blockade (ICB) immunotherapy and irreversible electroporation (IRE) of hepatocellular carcinoma. Selective transcatheter IA delivery of our aPD-L1-Z-Fer in a combination with immunogenic IRE treatment will permit efficient local delivery of immunostimulatory ICB molecules, allow an increase in the dosage and improve their safety profile. This salient combination of local ICB immunotherapy and immunogenic IRE offers the potential to significantly improve longitudinal treatment outcomes in liver cancer.